Administrative Program Enrichment Core

Project Summary (Administrative and Program Enrichment Core)
The Administrative and Program Enhancement Core (Admin Core) of UAB’s Nathan Shock Center (NSC) is
the oversight, administrative, and outreach arm of the UAB NSC as a whole. Under the leadership of Drs.
Steven Austad and Thomas Buford, the Admin Core will continue to manage, coordinate, publicize, and
integrate the diverse activities of the Center. Those activities include providing intellectual leadership,
developing and maintaining a premier aging research program, offering state-of-the-art Research Cores
targeted at the study of aging and made available to both internal and external researchers, and delivering
education, training and assisting with career development of new or emerging investigators. The Admin Core
also will be responsible for facilitating interactions with the other NSCs, the NSCs Coordinating Center (NSC3),
and relevant National Institute on Aging (NIA) staff. In consultation with the Internal and External Advisory
Committees, the Admin Core will issue annual evaluations and reports on each core’s performance, on the
performance of the NSC overall, and will make programmatic changes as warranted. This core will also be the
organizational unit responsible for promoting basic aging research at UAB, regionally, and nationally, seeking
particularly to attract late-stage trainees and early career researchers from allied disciplines into geroscience
research. To accomplish these goals, it will perform the following specific aims:
1. Provide day-to-day administrative support and financial management for the Center.
2. Promote and publicize Center Cores and educational outreach services.
3. Provide educational and training materials and activities in an inclusive and accessible environment.
4. Provide intellectual leadership and organizational activities to maintain a premier aging research program.
5. Foster interaction and synergies among Center Cores by regular communication and monthly in-person
meetings with key personnel from all the NSC Cores.
6. Pursue new, and leverage existing, institutional and private resources for the Center.
7. Stimulate interaction and coordination of UAB Shock Center activities with other Shock Centers, the NSC3,
and other research center programs via the Research Centers Collaborative Network (RCCN).
8. Perform annual evaluations of each core’s performance and of the performance of the overall NSC in
collaboration with the Internal and External Advisory Committees.